Building tools to study commensal-specific CD8+ T cells in the small intestine

PROJECT SUMMARY
Our understanding of immunity largely stems from models of infection with pathogenic microbes. However, the
vast majority of microbial-immune encounters occur as a symbiotic relationship with the commensal microbiota.
Recently, the contribution of commensal-specific T cells to host physiology has received significant attention.
These commensal-specific responses not only control microbiota containment but also promote microbial
diversity within the gastrointestinal tract. Conversely, aberrant immunity to commensal microbes has been
proposed to underlie pathologies of barrier tissues, including inflammatory bowel disease. A better understanding
of the properties and functions of commensal-specific T cell responses is therefore fundamental to studies of
tissue immunity in health and disease. Our long term goal is to better understand how commensal-specific T cell
responses contribute to barrier tissue homeostasis, and the objective in this application is to develop novel
transgenic mouse models to enable investigation of the mechanisms regulating induction and maintenance of
commensal-specific plasma cell responses in the gut. Our rationale for the proposed work is that uncovering
these mechanisms has the potential to translate into new therapeutic approaches. Our central hypothesis is that
commensal-specific T cells are sentinels of the gut tissue and contribute to intestinal homeostasis by limiting
translocation of commensal microbes. In this proposal, we will develop two technically innovative approaches to
generate commensal-specific CD8+ T cell receptor transgenic mice, and identify the microbial antigens they
recognize. Based on strong preliminary data, we will conduct two specific aims: (1) Develop Segmented
Filamentous Bacteria-specific CD8+ T cell receptor transgenic mice and (2) Identify the antigens recognized by
Segmented Filamentous Bacteria-specific CD8+ T cells. Our approach is innovative as it investigates new
mechanisms of immunity unique to commensal-specific T cell responses. The proposed work is significant
because it will establish new insights into the interaction and communication between commensal microbes and
immune cells in the gut environment and identify potential targets for therapeutic intervention in conditions of
chronic intestinal inflammation.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the mission of the NIH because a better understanding of the mechanisms of immune responses to commensal microbes will contribute to treatment of inflammatory, immune-mediated and autoimmune disorders. The proposed work is of particular relevance to host defense and immunity, and to immune-mediated diseases such as inflammatory bowel disease.